Infectious Diseases and Inflammatory Disorders Training Program

ABSTRACT
This is renewal application for an interdepartmental training program in Infectious Diseases and Inflammatory
Disorders. It is designed to foster the interests of outstanding medical students in biomedical research. In the
current funding periods (2014-2019), this program has offered training opportunities for a total of 47 trainees,
leading to publication/submission of 14 peer-reviewed manuscripts and 19 poster awards at national/regional
scientific meetings. Importantly, this enrichment program combines the faculty’s innovative research expertise
with unique institutional strengths for the education of medical students. Hands-on training will be provided by
23 faculty members from seven basic science and clinical departments at UTMB. The research themes will be
centered on infections and inflammation, especially on transmission of pathogens, the pathogenesis of
neuroinflammation, regulation of host inflammatory responses at the sites of pathogen entry (airway, skin, and
mucosa), regulation of leukocyte migration in the blood, liver brain and other organs, and vaccine/drug
development for the control of pathogens and tissue damage. Trainees (9 per year, 45 in total) will devote full-
time participation during a ten-week research period and will gain an in-depth knowledge of biological
concepts, modern research areas and tools. They will have the opportunity to choose basic, clinical,
translational, or behavior research projects. The program will match talented medical students with NIH-funded
faculty mentors, coupling the daily experience with an ongoing series of courses, summer research seminars,
research-in-progress discussions, oral presentations, and monitoring from faculty members. The specific
objectives are 1) to expose medical students early in their career to the excitement and technology of medical
research and to foster their investigative and analytical skills; 2) to encourage medical students to pursue a
career in basic and clinical research in the areas of infectious diseases and inflammatory disorders; and 3) to
provide valuable experience and references for students who wish to seek additional research training and
funding in the future. An adequate tracking system is in place for monitoring the career development of
trainees and the continued success of this training program. Our ultimate goal is to promote the professional
development for our medical students, enhancing their skills in research, oral/written presentations and
leaderships.

Public health relevance
PROJECT NARRATIVE This program will provide short-term, hands-on training for medical students in the area of infectious diseases and inflammatory disorders. It is designed to foster the interests of outstanding medical students in biomedical research and has successful outcomes in the past ten years of funding period.